ESTABLISHMENT OF A RECIPE DEVELOPMENT LAB FOR FURTHER TESTING AND DEVELOPMENT

The aim of this project is to carry out further testing and development, the latest being a compendium of 338 recipes assembled in a book entitled "The New American Diet." The aim of this project is to carry out further testing and development of low saturated fat, low cholesterol, low sodium, high complex carbohydrate and high fiber recipes.